Harnessing the Kohler Effect to Promote Motor Learning During Physically Assisted Rehabilitation

PROJECT SUMMARY: Effective gait rehabilitation must be engaging, intense, repetitive, and focused on
purposeful movement. However, patients after stroke can have neuromuscular or cognitive impairments that
make this ideal unattainable without physical assistance. Paradoxically, this assistance can hinder motor
recovery when patients habituate and reduce their sensorimotor engagement (the active correction of motor
errors). To counter habituation and improve learning during assisted gait training, this project newly combines
two theoretical frameworks: one from social psychology governing how social pressure impacts motivation, and
another from neuroscience describing motor learning as processes of error-driven adaptation and reinforcement
learning. Positive social pressure from working in a team can boost motivation compared to working individually,
which may improve rehabilitation by enhancing active error correction and increasing the value of successful
actions. This motivation enhancement in a team setting is termed the Köhler effect and is moderated by two
mechanisms: upward social comparison (comparing self-performance to others) and indispensability (when
success requires effort from all team members). Although these mechanisms have robust positive effects in
exercise and cognitive tasks, their role in motor learning is unknown. Addressing this gap could improve
rehabilitation care for millions who annually acquire and live with impairments from neurological injury. This
fellowship’s complementary specific aims target the impact of each Köhler mechanism on locomotor
rehabilitation. Aim 1 investigates how promoting upward social comparison affects sensorimotor engagement
and motor learning during assisted locomotion and Aim 2 investigates the effects of indispensability. To enhance
scientific rigor, a new model system is used: healthy participants walk on a treadmill and receive a standardized,
temporary neuromotor impairment by electrically activating their right hamstrings during leg swing. This
perturbation decreases participants’ net mechanical work during swing and shortens step length. The goal is to
reach a target mechanical work while viewing step-by-step work feedback. Unlike a kinematic target, which a
therapist can correct, the work goal can only be achieved if the participant contributes a significant amount of
effort to the rehabilitation task. Showing the separated participant and therapist work contributions is expected
to evoke upward social comparison. In Aim 2, therapist assistance is provided through a telerobotic system to
rebalance effort contributions, making the therapist “weaker” and participants indispensable. This project is
accompanied by a robust fellowship plan of interdisciplinary training that bridges neuroscience, rehabilitation,
social psychology, engineering, and post-acute stroke care. The major theoretical advancement will be a new
understanding of how sensorimotor engagement and motor learning are influenced by positive social pressure.
The results will serve to increase the effectiveness of rehabilitation interventions by shifting patient perceptions,
so they view themselves not as lesser contributors to a shared rehabilitation goal but as indispensable to success.

Public health relevance
PROJECT NARRATIVE After common neurological injuries like stroke, spinal cord injury, and traumatic brain injury, restoring walking ability and functional independence are some of the most important and challenging goals of physical rehabilitation. A drawback of many gait retraining approaches is that patients can quickly accommodate to physical assistance, causing them to lose sensorimotor engagement, which in turn impedes neuroplasticity and progress towards functional goals. The proposed work aims to enhance engagement and motor learning during gait retraining by harnessing positive social pressures; this will make physically assisted rehabilitation more effective, and in the long term, improve quality of life after neurological injury by stabilizing fall risks and reducing comorbid conditions and medical costs.